The role of Rpl5 haploinsufficiency in hematopoietic stem/progenitor cell function in Diamond Blackfan anemia

PROJECT SUMMARY/ABSTRACT
Anemia is an extraordinarily common condition that affects approximately 1 in 3 people around the globe.
Erythropoiesis is exquisitely sensitive to both endogenous and exogenous stress, which contributes to this
massive global disease burden. Genetic defects in ribosomes that lead to severe anemia are associated with
rare inherited bone marrow failure syndromes as well as more commonly acquired myelodysplastic syndrome.
The pathway from ribosomal protein haploinsufficiency to defective erythropoiesis in Diamond Blackfan anemia
(DBA) is complex and likely involves multiple factors (e.g. diminished GATA1 translation, heme toxicity and/or
nucleolar stress). Patients with DBA can undergo spontaneous remission such that chronic transfusions are
not required. This phenomenon is poorly understood using current patient registries and animal models.
Understanding normal pathways that lead to the resolution or improvement of anemia is critical in order to
advance therapies for DBA and other causes of anemia. The applicant is a pediatric hematologist/oncologist
who actively treats patients with all types of genetic and acquired anemias and her long term goal is to become
a physician-scientist with expertise in hematopoiesis. To achieve this goal, the candidate has proposed the
following training plan: 1) To develop expertise in isolation and analysis of hematopoietic stem/progenitor cells;
2) To further develop expertise employing mouse models and human hematopoietic stem cell culture to study
disease-specific mechanisms; 3) To develop an independently funded basic research laboratory; 4) To develop
into a successful physician-scientist focused on mentorship and collaboration. The candidate has assembled a
mentorship team with expertise in hematopoiesis and mouse models (Drs. Engel and Li). The environment at
the University of Michigan is highly conducive to the training of successful junior physician-scientists with
exceptional resources, educational and collaborative opportunities. The scientific proposal centers on the
hypothesis that DBA remission, even in these inbred mice, is based on a threshold effect on hematopoietic
stem/progenitor cells that responds to both exogenous and endogenous modifiers. The rationale for this
hypothesis is based on observations in our unique DBA mouse model where all neonatal Rpl5 (ribosomal
protein gene) mutant mice are born with anemia, which contributes to early mortality in some mice while others
survive and maintain normal hemoglobin characteristics throughout their lifespan. Aim 1 will determine if there
is an intrinsic defect in stem/progenitor cells and/or the bone marrow microenvironment in mutant mice by
examining transplantation of hematopoietic cells from different developmental periods. Aim 2 will test whether
cellular stress alters the niche and/or hematopoietic stem/progenitor cell function. Aim 3 will examine whether
cell cycle dysregulation is responsible for defective hematopoiesis during developmentally vulnerable periods
or during cellular stress. Completion of training under the guidance of senior mentors will enable the applicant
to develop into an independent physician-scientist with greater expertise in hematopoiesis.

Public health relevance
PROJECT NARRATIVE The goal of this application is to provide additional training for Sharon Singh MD, a Pediatric Hematologist/Oncologist, in the evaluation of hematopoiesis by investigating how ribosomal protein haploinsufficiency alters stem and progenitor cell function. The applicant will be guided by a team of senior mentors with expertise in stem cell biology, erythropoiesis and anemia with the goal of understanding how defects in protein synthesis affect red cell biology. There is a critical need for further work in this field, which has implications for a wide variety of disorders that lead to anemia in children; execution of the proposed aims will mature the development of a pediatric clinician-scientist with expertise in the evaluation of normal and abnormal hematopoiesis.